Statistical Methods for Evaluation and Validation of Diagnostic Tests

This multi-disciplinary effort by biostatisticians, radiologists, and medical physicists aims to develop innovative statistical methods for evaluation and validation of new and low cost diagnostic modalities. Specific Aims are (1) statistical methods for determining non-inferiority of diagnostic techniques; (2) statistical design and analysis methods for rapid and accurate evaluation of the chronological association and treatment efficacy of new radiological markers with disease outcome; (3) applying the statistical methods to clinical research and developing user-friendly software. Specific Aim 1 studies evaluation of non- inferiority for a new diagnostic test based on the receiver operating characteristics curve under various conditions (missing data, mixed data types, and clustered data), effects of covariates (non-inferiority after adjustment of covariates and identification of subgroups within which the new test is inferior, superior or equivalent), and Bayesian utility models. Specific Aim 2 studies a new cross-sectional case-control short- term follow-up (CSCCSTFU) design and analysis methods to estimate the chronological odds ratio of a new diagnostic test for a rare outcome. It will also propose methods to estimate the lower boundary of treatment efficacy for patients diagnosed by the new test. Mathematical theory and simulation studies will be used to understand the conditions in which the estimated odds ratio of the CSCCSTFU design can be generalized. Specific Aim 3 will apply results from Specific Aim 1to data from the Study of Osteoporotic Fractures and the Osteoporosis and Ultrasound Study to test whether and when quantitative ultrasound, peripheral bone mineral density (BMD), and biochemical bone markerscan serve as non-inferior or equivalent techniques to BMD of hip and spine for assessing osteoporotic fracture risks. It will also use results of Specific Aim 2 to determine whether the volumetric breast density and structural parameters of the new single X-ray absorptiometry technique can prospectively predict breast cancer in an on-going study of 15,000 women. An advisory committee of internationally recognized leaders in osteoporosis and breast cancer research will advise the research team on outreach to physicians and opportunities for ancillary studies. Research results will be disseminated through publication of software, research and tutorial papers in both clinical and statistical journals and by influencing position papers of professional organizations.